Translational Post-doctoral Training in Neurodevelopment

Project Summary/Abstract
This application, “Translational Postdoctoral Training in Neurodevelopment (TPND)” is a competing renewal to
request five additional years of funding in support of our Institutional Training Grant (T32). The TPND Program
at Boston Children's Hospital is designed to provide promising postdoctoral investigators (MD, PhD or
MD/PhD) with advanced training in essential translational topics ranging from preclinical considerations
through implementation of clinical trials for individuals with a range of neurodevelopmental disorders. Large
numbers of children, adolescents, and adults are affected by neurodevelopmental disorders that begin early in
life, and are rooted in aberrant brain circuitry. Most currently available treatments have had limited impact on
the course of neurodevelopmental disorders. Recent advances in genetics, neuroscience, and neuroimaging
have led to dramatic gains in our understanding of the pathogenesis of neurodevelopmental disorders. We now
have the possibility of developing mechanism-based treatments for many disorders in this field, and thus there
is an urgent need for training young investigators who will become the leaders in initiating and executing
research at the interface of these advances and ultimately improving the lives of individuals affected with these
disorders. TPND leverages the significant strengths of the Translational Neuroscience Center (TNC), the Fuss
Center for Neuropsychiatric Disease Research, and the Laboratories of Cognitive Neuroscience at Boston
Children's Hospital and Harvard Medical School to provide trainees with research experiences ranging from
pre-clinical and cognitive neuroscience labs through clinical trial involvement in neurodevelopmental disorders.
A key premise of this program is that effective research training in the field of translational neuroscience
requires both mentors with expertise in areas across the continuum of translational research with
neurodevelopmental disorders and ongoing programs to support the trainees to conduct innovative, high
impact translational research. The 17 faculty mentors will involve trainees over a 2-year period (3 new entrants
per year) with a range of state of the art methods in translational neurodevelopmental science that reflect core
areas of the TNC program including basic science and translational methods as well as application to clinical
populations in therapeutic trials for neurodevelopmental disorders. This research experience will be
supplemented with both didactic and clinical immersion experiences designed to provide trainees with the skills
needed to be successful independent investigators in this critical and emerging field. Ultimately this research
experience will have the potential to yield new treatments and insight that in turn will impact the field by
reducing the burdens and costs of care and costs to society that is now associated with neurodevelopmental
disorders. In addition, the TPND will develop models of interdisciplinary research training for promising young
scientists that will have a transformative impact on the field.

Public health relevance
Project Narrative Neurodevelopmental disorders such as autism spectrum disorders, attention deficit hyperactivity disorder, schizophrenia and intellectual disability are estimated to impact ~ 1 in 6 individuals in the United States. While currently available treatments have only limited impact on short- and long-term outcomes for most NDDs, advances in genetics and neuroscience are changing the landscape of research and opening possibility of bringing mechanism-based therapies to those affected with such disorders. The Translational Postdoctoral Training in Neurodevelopment (TPND) Program at Boston Children's Hospital will train postdoctoral neuroscience investigators (MD, PhD or MD/PhD) to develop and implement new medical and behavioral treatments for a range of neurodevelopmental disorders impacting children and their families.